Advanced 3D model of the Human Cornea for Keratoconus

Project Summary/Abstract:
The cornea, the tissue that makes up the front of the eye acts as a barrier between the environment and the eye
and focuses light onto the lens and then to the retina. Degradation of the cornea, commonly found in keratoconus
(KC), leads to progressive vision loss requiring ever increasing prescriptive correction and historically culminating
in corneal transplant. Despite the rise of the corneal crosslinking procedure to slow degradation, little is known
about the etiology of KC and/or the long-term effects of the crosslinking procedure on KC, including its long-term
efficacy.
In combination with a lack of in vivo models that accurately reflect KC, there is a lack of commercial corneal
models on the market. Current models, such as Mattek’s EpiOcular and EpiCornea consist purely of corneal
epithelial cells and are aimed at basic drug transport and irritation studies. While academic models are
significantly more advanced, recapitulating multiple cell types, none of the models recapitulate corneal curvature.
Further, few models incorporate flow analogous to the that of the tear film and aqueous humor: the tear film
represents a rich source of biomarkers that can be easily sampled non-invasively and aqueous humor generates
the pressure force that maintains the shape of the eye. Therefore there is a need to recapitulate flow and forces
in corneal models.
Overall there is a lack of physiological relevance in commercially available cornea models and a need for a more
advanced in vitro model.
We propose to develop a model that meets these needs. The key innovations of this model will be 1) the
incorporation of corneal geometry, and incorporation of 2) flow (tear film) and 3) pressure effects (IOP).
The Phase I effort will focus on providing a proof of concept for these key innovations. The phase II will focus on
demonstrating the model validity for KC through extensive comparison between healthy and KC diseased models
derived from KC patient cells. The model will be marketed initially to the KC research community for basic
research studies and pharmaceutical companies evaluating crosslinking and other KC therapeutics and then
extended to sales to the general corneal drug and research market.

Public health relevance
Project Narrative: Keratoconus is the most common corneal disease often resulting in severe degradation of vision. Corneal crosslinking has proven to be a helpful palliative for keratoconus patients, slowing disease progression. However, cases of regression and a lack of data cast concern on the long-term effects and efficacy of this treatment. Combined with a lack of etiological knowledge of the disease, lack of a recognized animal model, and interest in both palliative and curative treatments from pharmaceutical companies creates a need for an advanced human, 3D in vitro model of the keratoconus cornea.